COPD and Rural Health: Identifying Environmental Exposures Associated with Adverse Outcomes

Individuals with chronic obstructive pulmonary disease (COPD) who live in rural areas of the United States
have worse health outcomes compared with their non-rural counterparts, outcomes not completely
explained by higher rates of cigarette smoking. Both ongoing cigarette exposure and environmental
exposures other than cigarettes, including particulate matter (PM) air pollution, are associated with worse
COPD morbidity. Use of solid fuels (e.g. wood and pellet) for heating is common in rural areas and can
generate high concentration of indoor PM. However, there is a common belief is that rural areas are free
from air pollution, and rural residents are often not aware of pollution sources within their own homes and
communities. There are few studies that assess environmental exposures, their association with COPD
morbidity, and the risk perceptions of such exposures in rural areas of the United States. There is thus a
critical need to examine prevalence, predictors, and perceptions of environmental exposures in rural areas
in order to inform development of targeted, rural-relevant interventions designed to mitigate exposure. Our
long-term goal is to identify potentially modifiable environmental risk factors that contribute to greater
COPD morbidity in rural US, leading to future targeted interventions designed to improve outcomes. Our
overall objective for this application is to determine the association of environmental exposures with
respiratory morbidity in individuals with COPD living in rural areas, and to explore the risk perceptions of
such exposures. Our central hypothesis is that rural COPD patients are at increased risk of adverse
respiratory outcomes due to environmental characteristics both inside and outside of the home, exposures
which are influenced by social and economic factors that are common in rural areas. The rationale for this
project is that identifying the sources, health effects, and risk perceptions of environmental exposures will
inform development of a future comprehensive intervention that is sensitive to the needs and priorities in a
population where continued inhalational exposures are associated with disease progression and death. We
will recruit 75 individuals with COPD living in northern New England (NNE), and comprehensive
environmental exposure assessment will be paired with extensive clinical outcomes to address the
following aims: 1) To identify individual and community characteristics that are associated with
environmental exposures (e.g. solid fuel use, tobacco use, PM concentration) among those with COPD
living in NNE; 2) To quantify the relationship between environmental exposures (e.g. solid fuel use, tobacco
use, PM concentration) and morbidity in individuals with COPD living in NNE; and 3) To use semistructured
interviews and focus groups to explore risk perceptions, knowledge, attitudes, and behaviors
surrounding environmental risk factors and potential strategies to mitigate such exposures among
individuals with COPD living in NNE. The proposed research will generate crucial information on the
associations between environmental exposures and respiratory morbidity as well as the predictors of such
exposures in NNE residents with COPD. Results from this study will lead to future trials designed to
mitigate environmental exposures and improve health outcomes for individuals living with COPD in the
rural US.